Digital Technology Core

Project Summary: Digital Technology Core
Given limitations of conventional clinical assessments to precisely map change trajectories, our research
community increasingly seeks methodologies that incorporate continuous, real-world and objective
measurement of key features (e.g., mobility, cognition, sleep, medication taking, driving) using the pervasive
computing platform and methodologies of ORCATECH (Oregon Center for Aging & Technology). This new
approach has important application in many areas of dementia research beyond early detection, such as
caregiver/care recipient activities; agitation in institutional settings; and objective digital biomarkers (DB) of
sleep, physical activity, and the environment. Use of these technologies is not limited to assessment, but may
also deliver interventions, such as dementia care programs via home video. Given the growing use and
promise of DB and related technologies, this proposal will consolidate and build upon recent advances through
the Oregon Alzheimer’s Disease Research Center’s Digital Technology Core (DTC). Specific Aims are:
1. To maintain and make available for research, an OADRC dementia-specific focused Life Laboratory
cohort of research volunteers (healthy controls, MCI, and AD) who will have deployed in their homes
state-of-the-art sensing and pervasive computing platforms.
2. To obtain and make available for research, DB data on OADRC subjects.
3. To foster collaborative research involving DB and related technologies.